Integrative Medicine for Pain Management in Sickle Cell Disease

Project Summary/Abstract
Sickle cell disease (SCD) is characterized by chronic pain with underlying oxidative stress, inflammation,
hypoxia and central sensitization. Opioids are the mainstay of pain therapy for SCD, but are often ineffective
and associated with significant side effects. Potential benefits of using nonpharmacological therapy (e.g.
acupuncture, hypnosis, Tai chi, Yoga) have been reported, but not been systematically applied due to lack of
compelling evidence. In a humanized transgenic mouse model of SCD, electroacupuncture (EA) was
administered without using anesthesia or restraints. We observed individual differences in analgesia produced
by EA, and the intensity of pain reduction positively correlated with the expression of peripheral/central
inflammatory mediators. The underlying mechanisms of varying analgesia need to be explored in order to
develop an effective strategy to potentiate the insufficient pain relief of the poor responders to EA. The specific
aims of this project are to 1) determine whether the levels of specific inflammatory biomarkers (e.g. substance
P, TNF-α, IL-1β, IL-6) contribute to the varied analgesic effect of EA in sickle mice, 2) demonstrate the
mechanisms underlying hyperalgesia that target inflammatory biomarkers hamper the analgesic effect of EA in
poor responders, and 3) determine the correlations between the levels of selected circulating biomarkers and
the degree of acupuncture analgesia in sickle patients, and how they correlate with the changes of resting state
fMRI and specific brain neurometabolites with the intervention of acupuncture. The primary goal of the
mentored (K99) portion of the award is to give the candidate the comprehensive training in neuroimaging pain
research and clinical skills necessary for her to obtain a tenure track faculty position and successfully lead her
own independent research program. The majority of studies and training proposed by the candidate for K99
phase will be completed at the University of Minnesota, under the mentorship of Drs. Kalpna Gupta, Gregory
Vercellotti, and Donald Simone, with the collaboration of Drs. Xiao-hong Zhu and Al Beitz. The external
mentorship of Dr. Richard Harris from University of Michigan will guide the candidate in training related to MRI
techniques. Dr. Lonnie Zeltzer (UCLA), a leading physician scientist in integrative medicine, will also serve as a
co-mentor in advising the candidate on the clinically relevant aspects of the proposed studies with co-mentor
Dr. Vercellotti. These mentors and consultants are world-renowned experts in either molecular/physiological
pain research associated with SCD/cancer, or, pain neuroimaging, respectively. The University of Minnesota is
ideal for the K99 phase of the project because of the available resources, including faculty who are committed
to basic and translational pain research and mentoring, research-devoted magnetic resonance imaging (MRI)
scanners and state-of-the-art pain testing equipment, and ample laboratory and office space in Departments of
Medicine and Radiology. Upon completing the K99 portion of the award, the candidate will be well suited to
make the transition to a tenure-track faculty position.

Public health relevance
Project Narrative Chronic pain is one of the most significant features in SCD and pharmacological pain management for most sickle patients with chronic pain has unmet outcomes due to the limitations and side-effects of the current therapies such as opioids and hydroxyurea. Non-pharmacological approaches have shown potential benefits in SCD although with inconsistencies; the current proposal will study the underlying mechanisms of variable analgesic response to acupuncture in treating sickle pain in order to enhance the overall effectiveness of acupuncture from bench to bedside in SCD. The results from this translational research will fill a void in understanding mechanisms of non-pharmacological approaches in SCD and largely advance the application of acupuncture in sickle pain management.